Identifying cell type-specific autonomous and non-autonomous interactions in AD

ABSTRACT
A central question in Alzheimer's Disease (AD) is the role of cell type-specific changes associated with the
onset and progression of the disease. Genome-wide association studies have identified genes linked to AD,
and recent large-scale transcriptomic and proteomic studies of post-mortem brain tissue have highlighted
candidate genes and proteins with significant associations to pathological and clinical manifestations of AD.
Together, these genetic and molecular studies have implicated neurons, astrocytes, and microglia as key
players in AD pathogenesis and cognitive decline. However, these genetic and post-mortem profiling studies
cannot resolve the degree to which a change in cell type expression profile is cell autonomous, as opposed
to being a downstream effect of changes in other cell types. To tackle this question, we propose an innovative
mixed in vitro co-culture approach to understand the effects of cell types from donors with variations in
AD pathology and/or AD dementia on cell types derived from individuals with or without cognitive
decline or pathology. We use induced pluripotent stem cell (iPSC) lines from members of the Religious
Order Study/Memory and Aging Project (ROSMAP), for whom we have detailed pathological, clinical, whole-
genome sequencing, and post-mortem molecular data. Our preliminary data on monocultures from these
donor lines shows a high degree of concordance between in vitro and post-mortem transcriptomic, proteomic,
and proteinopathic data. This allows us to anchor our in vitro findings directly to patient phenotypes and
analyses of post-mortem brain tissue data. Based on this anchoring, our approach is to “mix and match” cell
type-specific cultures from different iPSC lines, thereby allowing us to disentangle which cell type-specific
changes in vitro are likely cell type autonomous, and which are induced non-autonomously by cells from a
donor with a different genetic background, pathology, and ante-mortem cognitive trajectory. Importantly, we
look for conserved, polygenic AD-associated signals in vitro that are present across donors with varied
genetic backgrounds, as opposed to directly characterizing the effect of a specific variant on cell type. Given
the highly multifactorial nature of AD genetic risk variants, we believe this approach allows for robust
identification of convergent cell type-specific effects associated with the disease.

Public health relevance
A central question in Alzheimer’s Disease (AD) is how different types of cells interact with each other to ultimately cause the degeneration of neurons, leading to clinical dementia. Here, we use an in vitro human cell system to culture mixtures of cells derived from donors with and without diagnoses of AD. Ultimately, this allows us to identify effects of cells from donors with genetic risk factors for AD on cells from individuals who did not show cognitive impairment or dementia in their lifetimes, thereby prioritizing specific biological pathways and signatures as potential targets for clinical intervention.